Dynamics of the cellular interactome

Cellular functional pathways have evolved through selective pressures and fitness benefits conferred through
protein intra- and inter-molecular interactions that comprise all protein conformational features and protein-
protein interactions, collectively referred to as the interactome. While the interactome is regulated by proteome
levels, it is also regulated independently by posttranslational modifications, co-factors and ligand levels, as well
as many local protein environmental factors, such as osmolyte concentration, pH, ionic strength, temperature
and others. Because fitness selection operates on processes that take place within the crowded intra-cellular
environment, our efforts have developed technologies to qualitatively and quantitatively measure highly evolved
interactome networks to improve comprehension of molecular functional landscapes in cells. To overcome
barriers and gain insight on cellular interactomes, our lab is developing novel in vivo chemical cross-linking
molecules referred to as Protein Interaction Reporter (PIR) technologies and new mass spectrometry methods.
These developments have provided the initial quantitative in vivo insights on interactomes in live cells. In this
project, we propose to further advance and apply Protein Interaction Reporter (PIR) technologies together with
advanced informatics, mass spectrometry and ion separation technologies to gain deeper insight on cellular
interactome dynamics during stress exposure. The primary goal driving our technology advancement is to better
understand how interactome dynamics shape functional landscapes inside cells. Questions we will address
include: what interactome changes are common and unique among cells exposed to heat, nutrient, and oxidative
stresses, how stress-dependent interactome dynamics are altered by HSP90, HSF1 and other inhibitors or other
perturbations and how do emerging mitochondrial therapies like Elamipretide that improve cell survival alter
stress-induced interactome dynamics. These efforts will reveal cellular interactome dynamics resultant from
multiple stress conditions as well as interactome changes that improve cell survival that can serve as targets for
future therapies for cancer, aging, cardiovascular, neurodegeneration, and many other diseases.

Public health relevance
Heat stress response is among the most fundamental stress adaptations and is critical for both prokaryotic and eukaryotic cell survival. This project will develop and apply quantitative in vivo cross-linking technologies and methods to gain greater insight on cellular interactome dynamics during stress response. These studies will enable improved understanding of many human diseases including cardiovascular, neurodegenerative, metabolic, aging and other mitochondrial diseases, as well as many types of cancers.